Modeling CHARGE Syndrome with Human Inner Ear Organoids

PROJECT SUMMARY
CHARGE syndrome is a congenital disorder characterized by dysmorphic features of inner ear structures, and
caused primary by sporadic mutations in CHD7, a gene encoding an ATP-dependent chromatin remodeling
enzyme. Results from our recent study revealed distinctive phenotypic differences between CHD7 KO and
S834F mutant inner ear organoids, suggesting that CHD7 regulates inner ear development through
multifaceted and context-dependent mechanisms. To investigate the chromatin remodeling-independent
function of CHD7, we will establish human embryonic stem cell lines harboring the D1812G mutation in a
putative WDR5-binding domain or the G1982W mutation in the SANT domain. Gene and protein expression
profiles of D1812G and G1982W cochlear organoids will be compared with those of S834F organoids with
abolished remodeling activity. Our previous results also revealed down-regulation of multiple deafness genes
in CHD7-null otic progenitors. To address if down-regulation of known deafness genes could account for
sensorineural hearing loss in individuals with CHARGE syndrome, we will test if these deafness genes are
downregulated in hair cells of cochlear organoids carrying defective CHD7. Ultrastructural and functional
properties of mutant hair cells will be compared to those of wild-type hair cells. Additionally, cell lineage tracing
will be performed to characterize drifted otic lineage specification in mutant organoids. To elucidate the
mechanisms underlying CHD7-dependent transcriptional regulation during inner ear development, we will
determine CHD7-binding loci, their transcriptional activity states and chromatin accessibility in human otic
progenitors through CUT&RUN, scATAC-seq and scRNA-seq. A potential role for CHD7 in posttranslational
histone modifications will be assessed by immunoprecipitation and ChIP-PCR. To assess possible
contributions of CHD7-dependent cell non-autonomous factors to otic progenitor differentiation, we will employ
a proteomic analysis of organoid conditioned media and test if some of the identified proteins can rescue
defective otic differentiation in CHD7 KO organoids. The results obtained from the proposed experiments are
expected to increase our understanding of the biological functions of CHD7 and will shed valuable insights into
the etiology of inner ear pathology in individuals with CHARGE syndrome.

Public health relevance
PROJECT NARRATIVE CHARGE syndrome is a congenital disorder caused by mutations in the CHD7 gene. In most cases, the development of the inner ear is affected, resulting in profound hearing loss and balance dysfunction. This study aims to elucidate how various mutations in CHD7 disrupt the development of the inner ear with the ultimate goal of identifying ways to prevent or reverse progression of hearing loss associated with patient-specific genetic mutations.